Engineered salivary gland tissue chips (Administrative Supplement)

ABSTRACT The goal of this supplement is to establish a workflow to upload data generated from our developed salivary gland tissue chip to the microphysiological (MPS) database (MPS-DB). Our data represents a new tissue model that is not currently represented in the MPS-DB. In addition, our model uses a novel device and includes a new disease model: salivary gland radiation damage. Overall, this supplement has 3 major goals: · Establish a workflow to upload data to the microphysiological systems (MPS) database (MPS-DB). Data for deposition are from past experiments focused on developing and validating the tissue chip, as well as ongoing drug screening experiments to verify the role of known radioprotective, sialogenic, and xerogenic drugs and screen for new drug candidates. · Upload our current protocols and model, including detailed standard operating practices and assays used to characterize and validate the tissue chips. · Upload our current data, which includes data to support reproducibility and relevance to phenotype and function of naïve salivary glands for both mouse and human tissue. Data generated by the parent grant includes/will include the following: · Salivary gland tissue mimetic o Viability o metabolic activity o gene expression o immunohistochemistry o calcium signaling o reactive oxygen species quantification o lipid peroxidation · Saliva secretion (in vivo) These data pertain to chip development, which shows reproducibility and relevance to human and mouse salivary gland phenotype and function. These data are detailed in Song et al., Communications Biology, 2021 and two forthcoming publications, which detail matrix and soluble cues to improve the longevity of tissue mimetic function. We have ongoing experiments focused on known and library-based drug screening for radioprotective, sialogenic, and xerogenic drugs. Hence, our current data set submission will enable workflow development alongside ongoing experiments, streamlining the deposition of data.

Public health relevance
Narrative The goal of this supplement is to establish a workflow to upload data generated from our developed salivary gland tissue chip to the microphysiological (MPS) database (MPS-DB). Our data represents a new tissue model that is not currently represented in the MPS-DB. In addition, our model uses a novel device and includes a new disease model: salivary gland radiation damage.